Sleep and circadian rhythm disturbances as risk and progression factors for multiple chronic pain conditions

PROJECT SUMMARY
Chronic pain affects more than one third of the U.S. population, incurring an annual health care cost of
$1 trillion. Some of the most prevalent “idiopathic” pain conditions that frequently co-occur, such as chronic low
back pain (cLBP), temporomandibular disorders, and fibromyalgia, are referred to as Chronic Overlapping Pain
Conditions (COPCs). Among various COPCs, cLBP has the highest prevalence and is one of the top 10 most
disabling conditions worldwide. Unfortunately, having multiple COPCs can further interfere with individuals'
adaptive pain coping and exacerbate pain-related disability. However, much focus to date has been placed on
individual anatomically-based chronic pain conditions and/or one COPC at a time, while little is known about
the mechanisms underlying progression to multiple COPCs. A paradigm shift from anatomy-based approaches
to mechanism-based approaches recognizing common and modifiable risk factors of multiple COPCs is crucial
in developing effective interventions to treat and prevent multiple COPCs. Emerging evidence suggests that
sleep and circadian rhythm disturbances—common clinical features across COPCs—that are modifiable, may
serve an important role in progression to multiple COPCs via enhancement of pain amplification and
psychological distress, which are two critical proximal determinants of multiple COPCs. For the present study,
we propose to recruit a total of 300 participants with cLBP (i.e., 200 with cLBP only vs. 100 with cLBP and
other COPCs) at baseline. Among these, 200 participants with cLBP only will be followed for 12 months. Sleep
and circadian rhythms will be assessed longitudinally (i.e., baseline and 6-month follow-up) using a cutting-
edge wireless EEG sleep monitoring device, 24-hour evaluation of the rhythm of urinary 6-sulfatoxymelatonin
(aMT6s), wrist worn actigraphy, and daily sleep diaries. Pain amplification (measured by quantitative sensory
testing), psychological distress (measured by well-validated self-report measures), and the number of pain
sites (measured by a well-validated pain body map) will be assessed at baseline, and 6- and 12-month follow-
up visits. The proposed study will (1) comprehensively characterize the severity of sleep and circadian
disturbances using ecologically valid multimodal ambulatory assessments among individuals with single and
multiple COPCs; (2) prospectively examine whether baseline and changes (0 to 6 months) in sleep and
circadian disturbances are associated with changes (0 to 6 months) in pain amplification and psychological
distress; and (3) whether pain amplification and psychological distress at 6 months and their changes (6 to 12
months) are related to progression (6 to 12 months) in the number of pain sites (i.e., a valid proxy measure of
multiple COPCs), while controlling for the effects of baseline sleep and circadian disturbances. The findings
from this proposed work will provide novel insights into potential mechanistic pathways underlying progression
to multiple COPCs, which may inform treatment and prevention strategies for these challenging conditions.

Public health relevance
PROJECT NARRATIVE Given that pain research has historically focused on the occurrence of one chronic pain condition at a time, little is known about the evolution of multiple, co-occurring pain conditions. The proposed study will seek to address this important issue and knowledge gap, as well as provide insight into whether sleep and circadian rhythm disturbances are the underlying catalysts in the progression from a single to multiple chronic pain conditions. Key findings of the proposed study can inform development of novel intervention and/or prevention approaches to improving the care of millions of adults with multiple chronic pain conditions.